VITaLS: Visual Thinking and Learning Strategies: Enhancing Health Professions Education through Virtual Reality Enabled Art Museum Experiences

Health professions schools are recognizing the important role of visual arts experiences in healthcare education to
improve clinical practice1 as it can provide insight into the human condition and suffering, and develop skills of
observation, analysis, empathy, and self-reflection. The use of Visual Thinking Strategies (VTS) to strengthen these
essential skills was pioneered by Harvard Medical School in 2004.2 Research findings examining the outcomes of VTS
methodology have demonstrated its effectiveness in improving visual diagnostic skills,3,4,5 promoting active listening and
analytical thinking,6 broadening empathetic understanding of patient experiences,7 and improving critical thinking and
problem solving.8,9 Since 2009 the Lowe Art Museum (LAM), at the University of Miami (UM), in partnership with the
schools of medicine and nursing, has used VTS in its programs where students work in interprofessional (IP) groups
participating in discussions about art. They have been shown to increase time spent analyzing clinical images and
discerning clinically relevant observations.10 Since they are typically conducted in museum galleries access to this
training is limited by proximity to museums. Furthermore, most programs offer one or two sessions and the opportunity
to practice and develop expertise is limited. We are developing a Virtual Reality (VR) platform to expand access to
training using the VTS methodology for students regardless of proximity to museum resources. VR provides immersive,
interactive, highly focused learning experiences in safe environments, free from other distractions, and enables access to
education from any geographic location. In addition, several studies have shown that learning retention is significantly
higher in VR.23,24,25 Our hypothesis is that VTS discussions in VR will result in measurable increases in tolerance
of ambiguity, communication skills, and readiness for interprofessional learning. We are developing a prototype
VITaLS museum gallery in VR to test the efficacy and scaling potential of teaching VTS in VR. Over a 3 month period
45 students in 5 IP groups (each comprised of medical, nursing, and physical therapy students) will participate in 3 VTS
sessions in our gallery. They will receive 3 pre- and post-test validated surveys: Readiness for Interprofessional Learning
Scale (RIPLS), Tolerance for Ambiguity scale, and Communication Skills Assessment Scale and one survey about their
experience of learning in VR. AIMS: Aim #1: to upgrade and customize our VR gallery and conduct the VR sessions;
Aim #2: to survey students about their experience and analyze the results; Aim #3: to survey participants on their
experience of learning in the VITaLS immersive virtual environment to ensure their perspective informs future
development. By the end of Phase 1 the data obtained from the surveys will be analyzed to assess the viability of this
training in VR. In Phase II we will expand our research to test our hypothesis by including schools that have never used
VTS or VR and conduct qualitative analysis of all Phase 1 and Phase II data to inform the development of a scalable
Minimum Viable Product. VITaLS can capitalize on the predicted exponential growth of the VR Healthcare Market
to provide a unique solution for improving vital communications, empathy, critical thinking and visual diagnostic
skills among IP groups of health professional students.

Public health relevance
Project Narrative Describe the relevance of this research to public health in, at most, three sentences. For example, NIH applicants can describe how, in the short or long term, the research would contribute to fundamental knowledge about the nature and behavior of living systems and / or the application of that knowledge to enhance health, lengthen life, and reduce illness and disability. Communication and teamwork failures have been found to be among the most common contributing factors in nearly all healthcare errors.13 Health professions schools are recognizing the importance of incorporating visual arts training such as Visual Thinking Strategies (VTS) into healthcare education because VTS has been shown to improve communications skills, observational skills, tolerance of ambiguity and readiness for interprofessional team learning. Our research includes the development of a prototype virtual reality platform to increase access to healthcare education with VTS training, which could have far reaching impacts in decreasing communication errors and improving healthcare quality.